Modeling Physiology and Behavior of Veterans to Avert Opioid Related Mortality Through Timely Intervention

Project Summary/Abstract
Opioid addiction affects people of all races, ages, gender identities, education, and income levels across the
United States. The epidemic has been intensifying in recent years, with relapse rates reaching close to 91%
(Kadam et al., 2017) and provisional data from 2020 indicating the highest number of overdose deaths ever
recorded in a year, over 88,000 (Centers for Disease Control and Prevention, 2020). Further, only 10-20% of
people struggling with addiction receive care for their OUD (Substance Abuse and Mental Health Services
Administration, 2020). An increasing body of literature exposes a population extremely vulnerable to opioid
addiction and overdose: United States veterans.
Veterans face unique challenges that predispose them to greater risk for misusing opioids such as
higher prevalence of and more severe pain than the general population (Nahin, 2017), and the stresses and
risks of deployment that often result in PTSD upon return to civilian life (Seal et al., 2012). Indeed, this group,
though not monolithic, may be generally resistant to support; half of military personnel reported that they
believe seeking help for mental health issues would harm their military career. Suicide rates continue to rise,
faster in the veteran population than in the non-veteran population, even despite the decrease in the population
proportion of veterans. In 2018, almost one in seven suicides in the U.S. was a veteran (“2020 National
Veteran Suicide Prevention Annual Report”, 2020). Mental health issues have an effect on substance use
disorders as well. Nationwide, the rate of overdose deaths in veterans increased by 65% from 2010 to 2016
(Lewei et al., 2019). The stressors of deployment during wartime that are often difficult to shake off upon return
to civilian life, incidences of injuries resulting in severe and often chronic pain, and the nuances of military
culture, combined with stigmas associated with OUD, perpetuate a detrimental cycle of addiction for veterans.
To address this, we are proposing the development of a novel solution that addresses the mental health
of veterans nationally via a first-of-its-kind remote monitoring and intervention software-as-a-service offering.
Our system builds upon our technology stack and learnings from clinical studies on individuals with OUD.
Given that substance use in the veteran population often precedes a deleterious cycle commonly resulting in
serious and persistent mental illness (SPMI) and sometimes even suicide, advanced and real-time remote
monitoring of the state of mental health would be an important indicator. This tool provides timely intervention
that addresses OUD and further averts the progression of SPMI as well as suicidal tendencies.

Public health relevance
Project Narrative With staggeringly high relapse and overdose rates and a dearth of treatment access and efficacy, the opioid epidemic is among the most pressing public health concerns of our time; drug craving states can be induced by a number of social, environmental, and contextual cues, there are often comorbidities with mental health issues, and other substance use disorders, and sustained, consistent, permanent behavior change is required to avert potential relapse events. An increasing body of literature identifies United States veterans as extremely vulnerable to opioid addiction and overdose, amongst other mental health related risks; the proposed work entails the development of precision opioid-use related intelligence which presents a unique opportunity to make an impact beyond aiding the process of addiction recovery, to help those struggling with other mental health challenges such as anxiety, PTSD, and suicidal ideation, and includes investigating the potential for physiological and behavioral monitoring of individuals with opioid addictions amongst the US Veteran population in order to improve adherence to treatment for opioid use disorder and aid in reintegration into civilian life. Behaivior will deliver real-time insights from internal and external factors that affect craving states based on wrist wearables and smartphone monitoring technology that can detect high-risk craving states and provide a trusted network of support individuals as well as care coordinators with just-in-time information to facilitate interventions which may avert life-threatening events, including overdoses or suicides.